Identifying the Interactions between Animal Toxins and Human nAChRs: The Role of Snake PLA2 in Interacting with nAChR alpha Subunits

PROJECT SUMMARY/ABSTRACT
Nicotinic acetylcholine receptors (nAChRs) are involved in a variety of fundamental physiological processes,
and dysfunction in these receptors is associated with many human disorders such as Alzheimer’s and
Parkinson’s diseases. The structure and function of human nAChRs are extensively studied; however, the
combinations of different nAChR subunits making various nAChR subtypes and their extracellular regions
binding a structurally diverse range of ligands, pose challenges in high-throughput (HT) and systematic
investigation of nAChRs. Fortunately, animal toxins provide a unique tool to study the structure and function of
nAChR because they have been fine-tuned through millions of years of natural selection to present high
specificity and selectivity towards specific proteins such as nAChRs. Our long-term goal is to identify universal
or selective animal toxins that interact with human nAChRs, and elucidate the mechanistic underpinnings
underlying their interactions. To achieve this goal, the overall objective of this application is to establish HT
approaches for identifying the interactions between snake toxins and nAChRs subunits, as well as deciphering
the role of toxins in interacting with human nAChRs by proposing the following three specific aims: 1)
Generate a snake toxin ORFeome library. The unique snake toxin transcript open-reading frames (ORFs) will
be identified from the existing venom gland cDNA library of a medically important snake (Crotalus atrox), and
individually ligated into a “donor” vector to create a snake toxin ORFeome library that can be directly used for
the interaction detections with any human proteins including nAChRs. 2) Determine the interactions of snake
toxins with human nAChR subunits. The interactions between snake toxins and human nAChR subunits, with
focus on the detection between venom phospholipase A2 (PLA2) and nAChR α subunits, will be identified by
utilizing a HT yeast two-hybrid (HT-Y2H) system, followed by co-affinity purification/mass spectrometry
(AP/MS). 3) Decipher the role of venom toxins in interacting with nAChR subunits. We will develop a HT
pharmacological assay to determine if snake toxins such as PLA2 act as agonist or antagonist against human
nAChRs. The nAChRs such as α1β1γδ, α3β4, α4β2, and α7, will be individually transfected into human cells
such as HEK293 for measuring the calcium dynamics and membrane potential elicited by PLA2-nAChR
interactions. The research results are expected to be impactful because: 1) it will provide valuable resources
for the scientific community, university faculty and students for subsequent biological research and biomedical
applications; and 2) it will provide a unique tool for HT and systematic investigation of the structure and
function of nAChRs. In addition, the project will create numerous opportunities for undergraduate students to
improve their research skills in biomedical science.

Public health relevance
PROJECT NARRATIVE The proposed project will generate a snake toxin ORFeome library and screen this library for identification of venom toxins such as PLA2 interacting with human nAChR α subunits by using high-throughput yeast two- hybrid analysis, followed by affinity purification/mass spectrometry and molecular dynamics simulations. Furthermore, the role of venom toxin such as PLA2 interacting with nAChR α subunits will be elucidated using a high-throughput pharmacological assay by detecting the calcium dynamics and membrane potential of human cells such as HEK293 transfected with different nAChR subtypes. The proposed project will have a huge impact on UTRGV researcher and students, because researchers in Texas Rio Grande Valley will get sustainable benefits from the facilities such as Sanger Sequencer and microplate reader provided from this project, and the project will create numerous research opportunities for UTRGV students to improve their research skills in biomedical science.